Mitigation of Cardiovascular Damage

PROJECT 3 SUMMARY/ABSTRACT
The general population continues to be at risk of exposure to ionizing radiation because of radiological
terrorism, including the detonation of improvised nuclear devices (IND) with an increased chance of radiation
injuries and cancer. Hence, the development of radiation mitigators is critical to ensure public health.
Moreover, minimally invasive biomarkers that predict the development of radiation injuries in particular organ
systems may aid in early treatment decisions. Until now, the majority of radiation countermeasures and
predictive biomarkers that are under development have been tested in models of exposure to X- or γ-rays
delivered by standard pre-clinical irradiators that provide dose rates of a few Gy per minute. In practice,
however, the majority of the IND-related radiation dose will be delivered over a time period of less than a
millisecond, and a significant component (10 to 50%) of the biological effects on survivors from a ground-burst
IND will be from neutrons. It is therefore important to understand whether radiation countermeasures that have
been developed and tested in animal models of conventional irradiation are also effective in scenarios of ultra-
high dose rates and neutrons with an IND-relevant energy spectrum. Project 3 is aimed at testing predictive
biomarkers and interventions in cardiovascular injury from IND-relevant radiation exposures. The project
makes use of a WAG/RijCmcr rat model of partial body irradiation with 5% bone marrow shielding that has
been characterized to study acute and delayed organ injuries from X-rays. Male and female WAG/RijCmcr rats
will be exposed to ultra-high dose rate radiation or IND-neutrons in the P01 Radiation, Animal and Dosimetry
Core and transported to the University of Arkansas for Medical Sciences for long-term simvastatin treatment
and follow-up to assess cardiac and vascular injuries. In collaboration with Projects 1 and 2, measures of
cardiac function and/or specimens of the heart from rats treated with the mitigators MIIST305 and lisinopril will
be examined. In addition, cohorts of rats will be exposed to IND-relevant radiation and treated with all three
countermeasures (simvastatin, lisinopril and MIIST305) to assess the feasibility of a polypharmacy approach
against multi-organ dysfunction. All countermeasures will be combined with an administration of pegylated
granulocyte colony stimulating factor, subcutaneous fluids and antibiotics in drinking water as a current
standard-of-care. Lastly, the multi-omics based CardioWatch panel consists of 11 proteins, metabolites and
lipids that, when upregulated in plasma at 2 weeks to 1 month after irradiation, predicts the development of
cardiac radiation fibrosis in animal models of γ- and X-ray exposure. Project 3 will determine whether the
CardioWatch panel is functional after IND-relevant radiation exposures. This is a highly translational project
that, in synergy with the research cores and other research in this program project will provide data from
realistic radiation scenarios due to an IND critical for the clinical implementation of predictive biomarkers and
pharmacological countermeasures of cardiovascular radiation injury.